A Federation Approach for the Professional Development of MOSAIC Scholarsin the Biological and Biomedical Sciences

The Federation of American Societies for Experimental Biology (FASEB) proposes a MOSAIC program that will
provide diverse scholars from historically excluded groups in biological and biomedical research with
professional skills needed to establish a successful academic career, coupled with mentoring, cohort support,
network development, and the fostering of resilience. This support will increase scholar retention in academic
research, thus diversifying the biomedical research enterprise and contributing to long-term improvements in
inclusive research environments at institutions and within scientific societies. In turn, this will lead to
advancements in health research outcomes due to the benefit of diverse perspectives brought to the effort to
address scientific challenges. FASEB has deep organizational experience in providing support to early-career
researchers. The project’s goals are to prepare five cohorts of diverse early-career researchers (postdocs
progressing to independent faculty) in research team management and provide support through training,
mentoring, and networking, leading to the MOSAIC scholars’ ability to persist in career advancement while
maintaining well-being through empowerment and resilience. Specific aims are to (1) develop research
management skill sets in diverse postdoctoral and early-career faculty researchers by leveraging FASEB’s deep
network of experts and mentors across scientific societies, as evidenced by scholar capabilities in setting up a
lab and progressing in research; (2) develop resilience in diverse postdoctoral and early-career faculty
researchers through identity development based on competence, performance, and recognition, as evidenced
by increased scholar confidence to overcome barriers and achieve stage-appropriate research career
progression both institutionally and through professional service; and (3) create sustaining support systems that
involve skills development, peer support, and safe spaces, as evidenced by scholar perceptions of the value of
such support in helping them persist in their career pathway while maintaining resilience and well-being.
FASEB’s MOSAIC program will implement a professional development series that covers skill sets important for
facilitating scholar career progression. The series covers foundational skills, professional skills, effective grant
writing, and academic career planning over four years. Resilience will be covered in a resilience and self-
advocacy course and through virtual support spaces. In a multi-mentor model, the scholars will be matched with
a mentor identified through FASEB’s extensive network to complement the mentoring they receive through their
home institutions. Mentoring will cover career issues, professional management, and work-life balance and will
foster the development of professional networks. Additional activities include financial support for conference
attendance; engagement of leaders at the scholars’ home institutions to align efforts; an online cohort support
forum; and opportunities to participate in networking, hone scientific communication skills, prepare for leadership
roles in scientific societies, and interact with FASEB committees.

Public health relevance
Project Narrative This project provides needed professional development, mentoring, networking, and psychosocial support to allow early-career biomedical researchers from historically excluded groups in science to persist and thrive in a research career, especially in the neuroscience and human physiology fields. This effort will increase the diversity and inclusion of the scientific biomedical workforce, contributing to the national capacity to advance health research outcomes and address scientific challenges.